Institute for Integration of Medicine & Science: A Partnership to Improve Health

Project Summary/Abstract: South-Central Texas is home to San Antonio and Austin, both among the nation’s fastest growing cities. San Antonio, the gateway to South Texas, is the 7th largest city in the US, whereas Austin is 11th largest. The region also includes many rural counties and several on the US-Mexico border. Given our demographics and rapid growth, our area foreshadows future challenges facing US healthcare, underscoring the national applicability of solutions devised by our hub. In 2006, UT Health Science Center San Antonio established the Institute for Integration of Medicine & Science (IIMS) as the academic home for translational research initiatives, training the translational science workforce, formalizing key strategic partnerships, and creating a community of scholars within a learning healthcare system. Building upon our optimized clinical and translational research infrastructure, IIMS is now in a 4th cycle of CTSA support in response to PAR-21-293. Our hub seeks to be exceptional in solving clinical and translational science (CTS) roadblocks, translating discoveries into improved healthcare outcomes across our population. We strive to make our vision a reality through robust strategies for supporting CTS across institutional partners and collaborating organizations, catalyzing successes for transdisciplinary research teams, and implementing programs that produce a creative, collaborative, and dedicated translational science workforce. We will achieve our goals through the strategic deployment of resources and expertise developed during 3 cycles of CTSA funding. Our proposal leverages optimized strengths across the spectrum of clinical and translational research to establish the capacity and infrastructure required for high-impact CTS programs. Thus, IIMS will pivot from the study of specific targets/diseases (i.e., clinical translational research) to the discovery of generalizable principles that apply to many targets/diseases (CTS), addressing rate-limiting steps and transforming translation from an empirical process into a predictive science. This guiding tenet is embedded within each Element and Module of this proposal, as well as across our pipeline of training and workforce development programs. We posit that synergies across hub partners will yield CTS innovations and contribute meaningfully to the National CTSA Consortium. Our over-arching Specific Aims are:
Catalyze the acceleration of CTS discovery and health outcomes impact within a vibrant academic home synergistically integrated with our strategic partners and actively engaged with our unique communities
Capitalize on our extraordinary population base to optimize our interdisciplinary clinical and translational science workforce
Implement innovative strategies for evaluation and continuous improvement across all IIMS programs
Focus strategically on dissemination and implementation of evidence-based CTS advances with high potential for advancing improved health and well-being for all, both regionally and across the Consortium

Public health relevance
The mission of the Institute for Integration of Medicine & Science is to improve human health and well-being by developing and disseminating innovative, measurable, patient- and community- focused best practices of clinical and translational science. Working synergistically with our partners and collaborators, we will accomplish this by strategic resource deployment, focusing on prevalent challenges in our region, including: 1) the health needs of our rural populations, 2) the special health issues facing military and veteran populations, 3) rate-limiting barriers to translational science progress, and 4) limitations in the translational science workforce required to fill in critical knowledge gaps and improve health in South-Central Texas and the US. Successful strategies for mitigating clinical translational roadblocks will be disseminated to our regional partners, as well as the National CTSA Consortium.